Tissue Engineered Total Disc Replacement in a Large Animal Model

Low back pain, which is commonly caused by intervertebral disc (IVD) degeneration, is the most common
source of chronic pain in Veterans. Current clinical treatments for disc degeneration, including spinal fusion,
are limited in that they do not restore healthy disc structure or function. To overcome this limitation, our group
has developed a whole, tissue engineered endplate-modified disc-like angle ply structure (eDAPS) composed
of engineered annulus fibrosus, nucleus pulposus and endplate regions. To date, we have completed the
long-term evaluation of the eDAPS in a small animal model, in addition to short-term evaluation in a large
animal, goat cervical disc replacement model. The parent Merit Award will evaluate how these engineered
discs function in a degenerative model, as well as their maturation over longer implantation times and with
remobilization of the spinal motion segment. Despite the promise of these engineered implants, the
inflammatory responses within the eDAPs and their potential for modulating inflammatory biological processes
within the intervertebral disc have yet to be evaluated. Thus, the overarching goal of this supplemental Award
is to evaluate the inflammatory milieu of the degenerating IVD in a large animal model, and to determine the
potential for an eDAPS implant to reset this milieu to enhance regeneration with remobilization. We will achieve
this goal via the following Specific Aims:
Specific Aim 1: Evaluate the inflammatory responses during intervertebral disc degeneration in a large animal
model. In this Aim we will induce degeneration in the goat cervical intervertebral disc via a previously validated
chondroitinase ABC injection degeneration model. Following induced degeneration, at 3 months, we will then
perform an in-depth analysis of the inflammatory responses involved in degenerative pathology by utilizing next
generation sequencing at the single cell level.
Specific Aim 2: Determine the immunomodulatory effect of an engineered disc replacement either following
injury or following remobilization of the disc replacement. To evaluate the immunomodulatory effect of
engineered disc replacements following degeneration (Aim 2a) we will again induce degeneration in the goat
cervical intervertebral disc. After the induced degeneration, at 3 months, a second surgery will be performed to
implant the eDAPS. Animals will be euthanized after 1 year of eDAPs implantation, and compared to animals
which underwent chondroitinase ABC injection but did not have eDAPs implantation. At the 1 year study
endpoints, immunophenotyping and inflammatory assessment will be carried out via single cell sequencing
followed by validation of specific cellular markers by immunohistochemical analysis. To evaluate whether the
mechanical loading environment influences the immunomodulatory effect of eDAPs (Aim 2b), we will utilize
remobilization surgeries following implantation. eDAPs will be implanted in the goat cervical spine and
immobilized via an internal metal fixation plate. A second surgery will remove the plate either 2 weeks or 2
months post-implantation. A set of implanted eDAPs will remain fixed and serve as a control. All animals will be
sacrificed 6 months following the initial eDAPs implantation. Immunophenotyping and inflammatory
assessment will be carried out via cytometric analyses and/or immunohistochemical analysis of inflammatory
and immune cell markers across whole IVD sections to determine how loading impacts the inflammatory state
of the engineered implant.
Overall, the proposed work will significantly improve the understanding of the immunomodulatory potential of
the eDAPs, as well as provide insight into the effect of mechanical loading on inflammatory responses within
the implanted eDAPs. This work contributes to a larger body of work which significantly drives the translation of
the eDAPs implant towards clinical use and advances the state of the art in spine therapeutics.

Public health relevance
Back pain is frequently associated with degeneration of the intervertebral discs (IVDs) of the spine and represents a significant health and economic burden, particularly to our active duty military and Veteran populations. Current treatments for disc degeneration, such as spinal fusion, are limited in that they do not restore healthy disc structure or function. The purpose of this supplemental award is to provide a more detailed analysis of the inflammatory milieu of the degenerating IVD and evaluate the immunomodulatory potential of a novel tissue engineered IVD replacement. This will be achieved via long term studies in a large animal model under clinically relevant conditions. Immunophenotyping of cells within the degenerated IVDs and engineered disc replacements will be used to evaluate the immunomodulatory effect of the engineered replacements and how loading impacts these features. This work will drive clinical translation of our tissue engineered disc, significantly improving treatment options for Veterans suffering from disc degeneration and back pain.